Stimulant and Polysubstance use, Inflammation and Sex Effects on Myocardial Disease in HIV (SPISE)

PROJECT SUMMARY/ABSTRACT
Heart failure (HF) and other cardiovascular diseases (CVDs) constitute a leading cause of death in people with
HIV (PWH). Compared to people without HIV, PWH have greater HF risk and we have shown that the difference
in risk may be greater in women than men. However, traditional HIV and CVD risk factors do not fully explain the
higher HF risk. Notably, symptomatic HF is often preceded by subclinical changes in left ventricular structure
and function detectable by echocardiography (echo), and even sooner by cardiac magnetic resonance imaging
(CMR). Recognizing myocardial disease determinants and the mechanistic contributors early in the disease
process is imperative to identify targets for HF prevention and treatment in PWH. Controlled stimulants like
cocaine and methamphetamine are known cardiotoxins, but their role in myocardial remodeling among PWH is
unclear. Stimulant use is higher among PWH than the general population, yet stimulant use is poorly assessed
in large HIV and CVD studies. It is either pooled with other substances or lacks details about patterns of use,
level of exposure, and synergistic influences with other substances – hampering our ability to understand the
potentially outsized role of stimulant use in the pathogenesis of HIV and myocardial disease in PWH. We propose
“Stimulant and Polysubstance use, Inflammation, and Sex Effects on Myocardial Disease in HIV (SPISE)” a
research program within the Multicenter AIDS Cohort Study (MACS)/Women’s Interagency HIV Study (WIHS)
Combined Cohort Study. Our findings from WIHS suggest that sustained (and not any) self-reported substance
use is associated with cardiac dysfunction, and sustained cannabis may have a protective effect, emphasizing
a need to assess substance use patterns and different influences of multiple substances. Furthermore, women
with HIV who reported prior cocaine use may have a larger HIV-1 reservoir than never users, even after adjusting
for ART adherence, which could explain persistent viremia in some women with implications to inflammation and
epigenetic maladaptation. SPISE’s overarching research goal is to rigorously characterize substance use
patterns (using serial urine drug toxicology measures and self-report) and determine its effect on structural heart
disease and myocardial disease through the longitudinal SPICE-echo and prospective SPICE-CMR studies,
respectively; whether DNA methylation and the inflammatory proteome mediates these effects; and how HIV
and sex influence the pathways. SPISE will establish a transdisciplinary infrastructure to comprehensively
investigate the biological basis of substance-associated myocardial disease at multiple points of the mechanistic
pathway. Our findings will be shared with the scientific community to stimulate and sustain research in substance
use and HIV. SPISE has the potential to transform current research paradigms that do not consider independent
stimulant use effects, promote new approaches for implementation research that acknowledge the importance
of substance use patterns, inform biomedical and behavioral interventions that are sex-specific, and direct
resource-intensive risk reduction strategies to those PWH who use substances and are at highest CVD risk.

Public health relevance
PROJECT NARRATIVE Cardiovascular disease (CVD), such as heart failure, is a leading cause of death among people with HIV (PWH), but it is not completely explained by traditional risk factors. Stimulants, like methamphetamine and cocaine, are known cardiotoxins associated with an increased risk of CVD; however, detailed patterns of stimulant use are not often included in large HIV and CVD studies. We propose a new research program to investigate patterns of multiple substances using serial drug toxicology measures from stored urine, with an emphasis on stimulant use, as key risk factors for echocardiography and cardiac MRI-measured structural heart and myocardial disease.